Treatment of Malaria-Associated Acute Kidney Injury and Progression to Chronic Kidney Disease

PROJECT SUMMARY
Malaria continues to be one of the top five leading causes of death in children under five, claiming the lives of
roughly half a million children annually. In most cases, the infection manifests as the so-called uncomplicated
or mild malaria, which resembles flu-like symptoms. However, if left untreated, malaria can rapidly progress to
severe malaria, a potentially life-threatening complication with mortality rates up to 90% at home and 20%
when patients are treated in hospital. Among the different manifestations of patients with severe malaria, ma-
laria-associated acute kidney injury (MAKI) has emerged as one of the most common maladies; it is associated
with poor prognosis and one of the strongest predictors of death. The impact of MAKI is beyond the associated
mortality. After an episode of acute kidney injury, the risk of developing long-term neurological complications
and chronic kidney disease (CKD) increases, even if the patient experiences a complete short-term recovery
and has no pre-existing medical conditions. In addition, people growing up in hyperendemic areas of malaria are
exposed to multiple episodes of malaria during their lifetime, with an estimated mean of 47.5 malaria infections
since birth, thus multiplying the chances of developing both MAKI and CKD. The management recommendations of
MAKI involve renal replacement therapy (RRT) in 25-75% of patients. The most commonly used interventions for
RRT include hemodialysis, peritoneal dialysis, hemofiltration, and kidney transplantation. However, implementing
these treatments in low-and middle-income countries, where malaria is endemic, poses multiple challenges, includ-
ing financial constraints, limited infrastructure, and scarcity of trained personnel. Therefore, alternative therapies
designed specifically for resource-limited regions are urgently needed to improve outcomes and reduce the
burden of MAKI and the development of CKD. The central hypothesis is that ferroptosis and the FasL/Fas
extrinsic apoptosis cell death pathways are pivotal in the pathogenesis of MAKI and that recurrent malaria in-
fections elevate the risk of MAKI development and progression to CKD. This research proposal aims to extend
our investigation into malaria-associated kidney disease, focusing on the therapeutic potential of targeting
these two cell death pathways for treating MAKI. Additionally, utilizing our innovative mouse model of MAKI
and in vitro systems, we will elucidate the mechanisms underlying the progression of MAKI to CKD and exam-
ine the impact of multiple malaria infections on disease outcomes.
The long-term goal of these studies is to develop alternatives to RRT to treat MAKI that can be implemented
in low-and middle-income countries where this therapy is largely unavailable and to understand how multiple malar-
ia infections contribute to the development of MAKI and the progression to CKD. To this end, we will (1) Targeting
the ferroptosis cell death pathway as a potential therapeutical target in MAKI. (2) Determine the role of the extrinsic
apoptosis pathway Fas/Caspase-8 in MAKI and its potential as a therapeutical target. (3) Investigating MAKI à
CKD progression following multiple malaria infections in our mouse model.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because it aims to develop new therapies for treating malaria-associated kidney injury and to study how this injury progresses to chronic kidney disease following multiple malaria infections. Successfully achieving these goals will help us understand the impact of recurring malaria infections on kidney health, addressing a critical gap in knowledge and improving health outcomes aligning with the NIH's mission.